Unpacking Emotion Inflexibility and Prospective Prediction of Affective Disease

PROJECT ABSTRACT/SUMMARY The prevalence of psychiatric disorders has reached nearly epidemic
proportions. Rates of common affective diseases (unipolar depression, anxiety and stress disorders) are high
across the lifespan and these diseases place a tremendous social and economic burden on the individual and
society. Clear evidence indicates that most affective disorders emerge at the intersection of pre-existing
vulnerability and significant, highly stressful, life-events. However, current models of emotion-related risk do
not adequately account for this confluence of biological, historical, and situational factors. In this investigation,
we build upon our prior work demonstrating broad associations between flexible emotion processing and
psychological health and adjustment, and in-flexible emotion and psychological risk and affective disease.
Specifically, we will recruit 400 adults in hospital following a potentially traumatic event (e.g., accident,
violence, fire, etc.) in order to model the influence of early emotion processing on trajectories of adjustment.
We focus our investigation on the super-ordinate construct of Emotion flexibility (EF) which encompasses the
ability to generate or up-regulate emotions, as well as to shift or down-regulate emotions according to needs
and/or environmental demands. EF is well-suited to inform models of emotion-related risk and adjustment as it
characterizes an optimal balance of two biologically-based, constituent dimensions: “bottom-up” threat-related
processing and “top-down” cognitive control increasingly recognized as central to all emotion processing. We
propose rigorous methods to assess EF and related processing in-vivo in lab and via experience sampling.
Moreover, we will follow participants to 18 months post event so as to effectively model the association
between emotion processing and trajectories of adjustment, while also considering established influences such
as physical health status, psychiatric history, childhood maltreatment, daily stress/hassles, and social support.
In particular, we will incorporate recent developments in advanced statistical modelling to better characterize
the complex and interactive influence of historical and contemporary factors on moment-level emotion
processing, EF and adjustment. Broadly, this project is in line with the most recent NIMH strategic plan and will
contribute to more complex models of the most common affective diseases, including facilitating the charting of
illness trajectories to help determine when, where, and how to intervene. Moreover, this research will directly
examine how variation in key systems can influence emotion-processing and adjustment to aversive life
events, fitting complex influences more directly into models of risk for the most common and burdensome
affective diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE/NARRATIVE Emotion-related psychiatric disorders, including depression and anxiety, affect a considerable portion of adults in this country and rank as many of the most burdensome diseases worldwide. In this investigation, we will follow an at-risk sample of adults in order to better understand how one key pathway, relating to how individuals process emotion, influences risk for emotion-related diseases over time. In addition, we test the role by which certain other factors, both contemporary and historical (physical health, life stress, social support, psychiatric treatment history, or childhood experiences) may increase or decrease risk via this particular pathway.